Astrocyte-specific exosomes as a platform for biomarker discovery in multiple sclerosis

Astrocyte-specific exosomes as a platform for biomarker discovery in multiple sclerosis.
Acute and chronic neuroinflammation are major drivers of MS pathology, which are difficult to quantify in vivo.
Thus, there is a significant unmet need for biomarkers that reliably reflect these processes. Astrocytes are highly
sensitive indicators of CNS pathology and active drivers of a wide range of pathological processes in MS. Like
most cells, astrocytes secrete a class of ultrasmall microvesicles termed exosomes. Because exosomal content
changes with the functional state of the parent cell, the cargo of astrocyte exosomes may provide a window into
the specific activation states of astrocytes. We have developed a strategy for isolating astrocytespecific
exosomes from patient plasma, based on the combined expression of glutamate/aspartate transporter (GLAST)
and glial fibrillary acidic protein (GFAP). In this proposal, we are exploring astrocyte-derived exosomes as a
platform for biomarker discovery in acute demyelination and secondary progression in MS. In specific aim 1, we
will comprehensively validate that GLAST+/GFAP+ exosomes are astrocyte-derived. In specific aim 2, we will
explore the utility of plasma-derived GLAST+/GFAP+ exosomes to provide biomarkers for two distinct MS
disease states – acute white matter demyelination and MS progression. To this end, we will profile the exosomal
miRNA content of MS patients with gadolinium-enhancing white matter lesions and with secondary progressive
MS and determine the miRNA signatures that are specific to each condition. Identifying exosome-based
biomarkers for lesion formation and MS progression would constitute a major advancement for MS patient care
and clinical trials. In follow-up studies, we will validate these biomarkers in larger MS patient cohorts.

Public health relevance
Project narrative Blood tests that accurately measure demyelination and disease progression in multiple sclerosis patients are urgently needed. We are exploring whether ultra-small vesicles that are shed by brain cells and are detectable in peripheral blood, provide suitable biomarkers for these processes.